Activites4Care: A Digital Platform to Enhance Caregiver Well-being by Providing Customized Activities that Improve Quality of Life for People Living with Dementia

PROJECT ABSTRACT
A critical unmet need of >6 million people living with Alzheimer’s Disease (AD) and AD related dementias
(AD/ADRD) is the lack of meaningful activities, a common concern of individuals and family caregivers. With
disease progression, cognitive and functional decrements fundamentally alter a person’s ability to engage in
activities which in turn results in negative sequelae including behavioral symptoms, poor quality of life, and
increased healthcare utilization. In response, Plans4Care, Inc, a company dedicated to developing digital
solutions to support caregivers and people living with dementia (PLWD), proposes a Fast-Track SBIR to build
and test a new digital platform, Activities4Care. As pioneers in activity programs for PLWD, our team seeks to
transform dementia care by bringing our evidentiary in-person protocols to a digital platform accessible via
computer, tablet or smartphone. Our proposed platform will provide caregivers with detailed personalized,
actionable instructions for using meaningful activities that our software (Company IP) dynamically adjusts
based on caregiver inputs concerning PLWD cognitive/functional abilities, interests, and care context. The
Specific Aims are as follows: Phase I - Aim 1: Develop a clickable prototype mapping 5 common activities to
PLWD, caregiver, and environmental characteristics from which actionable, customized activity plans are
generated. Phase I - Aim 2: Determine feasibility (caregiver can use platform to identify an activity, respond to
brief evidence-based questions and review the generated activity plan); acceptability (appeal, appropriate-
ness); and usability (ability to navigate) using validated survey measures with 25 diverse caregivers. Prototype
testing will be followed by focus groups with the same 25 caregivers to obtain qualitative feedback and
preferences for multi-media approaches to demonstrate best practices for implementing activities. At the
conclusion of Phase I, quantitative milestones (go-no go) to transition to Phase II are: 1) 25 caregivers
enrolled; 2) 75% complete assigned tasks: onboard, identify activity of interest, review an activity plan
(feasibility); 3) 75% rate Activites4Care acceptable and 4) 75% rate navigation as easy (usability). Phase II -
Aim 3: Incorporate Phase I prototype testing and qualitative feedback to complete build-out and integration of
the platform. This aim will further develop our solution into a commercial product. Phase II - Aim 4: Conduct a
two-group randomized, wait-list controlled trial (n=160) with research partners (University of Pennsylvania,
Department of Veterans Affairs) to evaluate if: a) caregivers use Activities4Care to generate activity plans; b)
caregiver confidence using activities improves, c) caregivers save time; d) caregiver well-being improves; and
e) PLWD behavioral symptoms and acute care utilization are reduced. This aim will formally provide evidence
for the benefits of Activities4Care. Conventional digital programs offer general tips for activity use; our solution
customizes activity to abilities, interests, and other factors. The commercialization potential of an easy-to-use
digital tool for customized activities is novel and offers an effective, scalable solution to a critical unmet need.

Public health relevance
NARRATIVE Family caregivers and people with Alzheimer’s Disease (AD) and AD related dementias (AD/ADRD) identify the lack of engagement in meaningful activities as a critical unmet need throughout the disease trajectory. Our company, Plans4Care, Inc, dedicated to bringing digital solutions to dementia care, proposes a Fast-Track SBIR to build a new program, Activities4Care which delivers activity plans that are customized to people with AD/ADRD, caregivers and environments on a smartphone, tablet or computer, provides detailed instructions for implementing activities, and enables access to telephone sessions with a care advisor as needed. Standardized measures will assess feasibility, acceptability and utility of the activity module in Phase I, while in Phase II, a randomized trial with 160 caregivers enrolled through the Department of Veterans Affairs will evaluate its effectiveness to improve caregiver confidence and wellbeing and reduce time caregiving and behavioral symptoms and health care utilization of people with AD/ADRD.